Wearable Heat Related Injury Risk Analysis (WHERA) system Resubmission

PROJECT SUMMARY/ABSTRACT
With climate change unfolding, temperature-related illnesses, such as hypothermia and hyperthermia, affect
increasing numbers of individuals worldwide every year. Core body temperature has been shown to be a
reliable diagnostic of temperature-related illness and its severity, but the current measurement methods are
inadequate because they fail to combine minimal invasiveness with high measurement accuracy. Dual-heat
flux thermometry is a promising new way of measuring core body temperature at the skin surface, but thus far
has lacked precision and compactness due to the limitations of traditional temperature sensing elements. To
solve this problem, our team has synthesized thermally sensitive polymers and applied them in a dual-heat flux
architecture. By varying the ratio between the polymer building blocks, our team was able to obtain thin films of
polymer with thermal resolution of 10 mK. These wearable patches will provide real-time core body
temperature information to individuals at risk of temperature-related injury such as firefighters, industrial and
farm field workers, military personnel, athletes, as well as to patients requiring core body temperature
monitoring for clinical reasons.

Public health relevance
PROJECT NARRATIVE This effort addresses the current challenges of core body temperature measurement. As a main indicator of temperature-related illnesses, this metric is important to monitor in a non-invasive fashion for numerous occupations and clinical scenarios. We are developing a wireless wearable electronic core body temperature sensing patch that is based on a novel class of thermally-sensing polymers.